Can services to address Veterans social determinants of health reduce their suicide risk?

Background: Despite accessible and effective suicide prevention strategies offered by the Veterans Health
Administration (VHA), Veteran suicide remains elevated compared to the general US population, indicating a
continued need to identify Veterans at risk for suicide and provide interventions to prevent suicide. Suicide
prevention can be enhanced when health care systems integrate dynamic social determinants of health (SDH),
such as housing instability, justice involvement, and unemployment.
Significance/Impact: The goal of this HSR&D Veteran Suicide Prevention project is to address prevention
activities that occur “upstream” by examining how services addressing SDH may also prevent suicide among
Veterans, key objectives in the VA’s National Strategy for Preventing Veteran Suicide 2018–2028.
Innovation: This study will integrate a public health perspective to suicide prevention through a lens of SDH.
Rather than focusing specifically on medical intervention, this study will explore—based both on a natural
experimental design using existing administrative data and on gathering the perspectives of key informants
and Veterans—how addressing SDH can decrease suicide risk, taking into account the complex needs of
Veterans who may be at risk for suicide.
Specific Aims: This study aims to determine whether VHA services tailored to address SDH may also have an
added benefit of preventing suicide mortality; identify organizational assets and opportunities to improve how
SDH-focused services address suicide risk among Veterans; and engage Veterans in identifying ways to
integrate suicide prevention into VHA programs that respond to SDH.
Methodology: The proposed research is a concurrent mixed methods design. Retrospective quantitative
analyses will examine how VHA services tailored to Veterans’ SDH (i.e., housing instability, justice
involvement, unemployment) may protect against suicide mortality and morbidity. A mixed methods
environmental scan will include a questionnaire of staff/key informants and qualitative interviews. Qualitative
interviews with Veterans with a history of suicide risk will explore how services to address SDH respond to
those needs.
Implementation/Next Steps: This project will lead to actionable implementation projects: increased linkages
to services for SDH among Veterans with histories of suicidal crisis as well as enhanced training for providers
to integrate suicide prevention into services addressing SDH, and vice versa. We have convened an array of
VA operations partners—Social Work, VHA Homeless and Justice Programs, employment programs, and VA
Office of Mental Health and Suicide Prevention—to facilitate removing siloes around SDH and suicide
prevention in VA, amplifying VA’s current infrastructure to bolster suicide prevention.

Public health relevance
The rate of suicide among US military Veterans is approximately 50% higher than among non-Veterans. Suicide is a complex phenomenon that is highly associated with social determinants of health (SDH) including housing instability, justice involvement, and unemployment. Using existing Department of Veterans Affairs (VA) administrative data, and environmental scan of VA support programs, and qualitative interviews with VA support program staff and Veterans, this study will determine whether and how services to address SDH mitigate Veterans’ risk of suicide. Results will lay the groundwork to develop implementation trials to bolster VA and community social support services as non-medical components of suicide prevention for Veterans.